Molecular and Cellular Basis of Cardiovascular Disease

SUMMARY / ABSTRACT
Cardiovascular diseases remain the leading cause of death in the United States and worldwide and are
a significant cause of premature death, disability, and loss of quality-of-life. Novel technologies and
approaches to determine the mechanisms that cause or contribute to cardiovascular diseases have
become increasingly powerful, but these approaches have also become increasingly specialized.
Multidisciplinary efforts that bring together investigators with complementary knowledge, tools and skills
and integrate laboratory and patient-based research are essential for ongoing efforts to leverage
information about mechanisms of disease into rationale therapeutic approaches for treatment. Thus,
the need for broadly trained scientists who can adopt innovative technologies, assemble tools from
different disciplines, and bridge basic, translational, and clinical science is greater than ever. The
overall goal of the UCSF Training Program in the Molecular and Cellular Basis of Cardiovascular
Disease is to train a diverse group of investigators who will be at the forefront of cardiovascular
discovery and disease research. Toward this goal, this training program will: 1) attract talented
PhD-trained postdoctoral scientists from a broad national and international applicant pool and from an
outstanding group of MD- and MD/PhD-trained researchers from UCSF's Cardiology and other clinical
fellowships to postdoctoral training in cardiovascular research; and 2) leverage the strong
multidisciplinary research environment in UCSF’s Cardiovascular Research Institute (CVRI) to provide
outstanding scientific training in the context of research programs focused on cardiovascular biology
and disease. The Program brings together a diverse and outstanding group of mentors with a
common interest in cardiovascular biology and a commitment to mentorship and training of a diverse
group of postdoctoral scientists. The heart of this training program is formulation and execution of a
substantial research project relevant to cardiovascular biology and development of professional skills
under the guidance of a faculty mentor. The Training Program includes state-of-the-art, cutting edge
research opportunities in laboratories that span basic, translational, and patient-based,
clinical research. Program trainees benefit from the cohesive, multidisciplinary training
environment in CVRI, and the robust intellectual and scientific environment in the CVRI and at UCSF
more generally. Trainees also benefit from co-mentoring, peer-mentoring, ready access to collaborators
and colleagues with overlapping but complementary interests and expertise, and extensive and robust
didactic training in the Responsible Conduct of Research, Training in Clinical Research, if
appropriate, and a strong emphasis on reproducibility and rigor in scientific examination.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases remain the leading cause of death in the United States and worldwide and are also a significant cause of premature death and disability. Multidisciplinary efforts that bring together investigators with complementary knowledge, tools and skills and integrate laboratory and patient-based research are essential for ongoing efforts to leverage information about mechanisms of disease into rationale therapeutic approaches for treatment of cardiovascular diseases. This Training Program offers an exceptional faculty in a strong multidisciplinary, diverse, and collaborative environment at UCSF, a top biomedical research institution, to train future leaders in cardiovascular research.